CONCENTRATION-CONTROLLED COMBINATION ANTIRETROVIRAL THERAPY

Heterogeneity in the response to antiretroviral drugs is well described. Pharmacologic variability may contribute to this heterogeneity and can be minimized by employing target concentration strategies. GCRC 540 is a randomized, open-label study of a safety, tolerance, and antiviral activity of a concentration-controlled regimen of zidovudine, lamivudine, and indinavir compared with the standard doses of these three agents in 40 antiretroviral-naive, HIV-infected adults with CD4 lymphocytes > 100 cells / uL and plasma H IV-RNA > 5000 copies / mL.